VARIABILITY IN GH AND GONADOTROPIN SECRETION IN WOMEN

Fifteen eumenorrheic women in the early follicular phase of the menstrual cycle will be studied on two occasions separated by a month. Blood samples will be studied on two occasions separated by a month. Blood samples will be drawn at 10 minute intervals for 24 hours for GH and gonadotropin determination. Data will be analyzed by standard pulse detection techniques. COMPUTER ONLY.